Multilevel RCT of Rural Community Sun Safety for Young Children in Sports

PROJECT SUMMARY
Melanoma is the deadliest form of skin cancer, disproportionately affecting rural areas of the US and driving up
a disproportionate cancer burden. Children living in these rural and underresourced communities commonly
experience multiple health disparities, including increased risks for skin cancer over time. This is due to more
frequent and intense outdoor exposures to harmful ultraviolet radiation (UVR) from the sun, where the chances
of sunburn are substantially increased. Unfortunately, there are no evidence-based sun safety interventions with
durable effects on protecting children in these settings, and especially while playing outdoors. How to safely
promote young children's outdoor playtime while still adequately protecting them from harmful UVR exposure is
a vexing research challenge in rural cancer control, and one that requires a multilevel public health approach to
cancer prevention. In direct response to this need, we designed a multicomponent, multilevel sun safety
intervention for young children (ages 3-6) enrolled in recreational sports programs across 2 rural states (UT,
WV). Recreational sports programs are naturally-occurring opportunities for early cancer education and
protection in an adult-supervised setting. Grounded in an ecologically-valid theory of shaping children’s health
behavior, our intervention promotes recommended sun safety strategies and adaptations at the individual, social,
and environmental levels. In a preliminary trial, we delivered this intervention in 2 rural communities'
developmental baseball programs (among N=17 teams of female and male players). Intervention leagues,
teams, coaches, and players evidenced significant improvements in key outcomes, and greater than among
controls. Now, we propose a more stringent test of this intervention in a two-arm cluster-randomized trial in 16
counties in 2 rural states (UT, WV) matched for skin cancer burden and other community-level factors. The trial
will address 16 leagues, 64 teams, 128 coaches, and 640 players: primary outcomes include directly-observed
sun protection behaviors during recreational sports practices and games. Area-wide UVR and environmental
scan data will be obtained from geocoded locations and considered in explanatory models. Secondary endpoints
include parent-reported child sun protection and sunburn. Multilevel mechanisms, processes, and moderators of
the intervention’s impact on child sun protection will be included, as well as intervention delivery-related effects
to help guide future tailoring. This project has the potential to promote lasting changes in children's sun safety
behaviors during a sensitive biological stage. It will do so in rural and medically underrepresented communities
that are among the most in need of effective cancer control strategies, using approaches that can be scaled-up
statewide and to other regions of the country to help reduce cancer disparities.

Public health relevance
PROJECT NARRATIVE Children residing in rural and underserved areas of the US are at high risk for skin cancer over the lifecourse and require early intervention for sun safety programming in settings with intense ultraviolet radiation exposure levels from the sun. We will test a new skin cancer prevention program for young children living in these communities that is delivered through youth sports leagues. This project will increase our understanding of how to deliver health behavior interventions in community recreational settings with rural and underserved populations.